Development of novel epigenetic biomarkers and detection reagents for aging

SUMMARY
Aging, Alzheimer’s disease, and related dementias (AD/ADRD) are associated with a deterioration of
chromatin structure. This deterioration is caused in part by dysregulation of histone post-translation modifications
(hPTMs), which play driving roles in regulating chromatin structure and function. Restoration of healthy chromatin
structure through manipulation of hPTMs can increase longevity and even reverse aging phenotypes. Therefore,
a better understanding of chromatin regulation and aberrant hPTM patterns could lead to identification of novel
therapeutic targets and biomarkers of aging and AD/ADRD. Notably, hPTMs do not function in isolation, and
studying hPTM combinations provides essential information that cannot be gleaned from single hPTMs. Certain
combinations have been well studied and considered canonical, whereas noncanonical combinations are rarer
and generally associated with dysregulation. As such, further study of hPTM combinations is promising for
clinical research to discern healthy vs. dysregulated noncanonical hPTM combinations. Discovery and study of
coincident hPTMs has been limited because 1) most assays require a priori knowledge of a target, and 2) most
reagents are specific to a single hPTM. These limitations hinder discovery of new hPTM combinations and cannot
distinguish if co-occurring PTMs are on the same or separate histone tails. Thus, new approaches and tools are
needed to discover and study pathogenic hPTM combinations to enable the next generation of research for aging
and age-related diseases, including identification of novel biomarkers and accelerated therapeutic development.
Here, EpiCypher is partnering with Dr. Nicolas Young (Baylor College of Medicine) to develop
AgingPTMTM, a novel platform to study aging-associated combinatorial hPTMs (acPTMs) in tissue. This platform
will enable the identification and study of new therapeutic targets and biomarkers for aging and AD/ADRD. There
are three central innovations in this project: 1) the application of novel unbiased proteomic analysis to identify
noncanonical hPTM combinations specific to aging and AD/ADRD, and 2) the development of new assays to
further study acPTMs, 3) enabled by novel detection reagents composed of binding domain fusion proteins (i.e.,
acPTM Sensors). This platform will enable new studies into the mechanisms that drive aging pathology and
identify new therapeutic targets and/or disease biomarkers. In Phase I feasibility studies, we identified aberrant
hPTM combinations that increase with age in the brains of mice (acPTMs). We also showed that overexpression
of an hPTM regulator is associated with a reduction in acPTMs and increased longevity, suggesting these
acPTMs are therapeutic targets. In Phase II, we will develop a collection of three acPTM Sensors and
complementary spike-in controls (Aim 1), and rigorously validate them for multiple applications, including
genomics, in various tissues (Aim 2). In Aim 3, we will optimize commercial-scale manufacturing of the three
Sensors and spike-in panels, assemble beta kits for genomic mapping, and apply our novel Sensors to validate
these aging-associated hPTMs in human brain.

Public health relevance
NARRATIVE Aging and neurodegenerative diseases, such as Alzheimer’s disease and related dementias are associated with deterioration of chromatin structure. Chromatin structure is informed by combinatorial chromatin features, which can be informative biomarkers but are difficult or impossible to study without complex proteomics methods. Here, EpiCypher is developing a pipeline for the unbiased discovery of aging- associated combinatorial marks and development of cognate detection reagents to identify and validate novel biomarkers and therapeutic targets of aging and age-related diseases.